The neural basis of fatty acid taste

Project Summary
Fat represents a calorically potent food source that yields approximately twice the amount of energy as
carbohydrates or proteins per unit of mass. Dietary lipids are comprised of both triacylglycerides and fatty
acids, and growing evidence suggests that it is the free fatty acids that are detected by the gustatory system.
The highly palatable taste of fatty acids promotes food consumption, activates reward centers in mammals,
and contributes to hedonic feeding that underlies many metabolism-related disorders. Despite a role in the
etiology of metabolic diseases, little is known about how dietary fats are detected by the gustatory system to
promote feeding. We have shown that fatty acids function as appetitive tastants and identified the first putative
fatty acid receptor in the fly. This proposal seeks to identify the cellular and neural circuit principles that
underlie the detection and processing of fatty acids. In addition, these experiments will investigate whether
flies are capable of discriminating between different appetitive tastants, and whether fatty acids and sugars are
processed by shared or independent neuronal circuits. The completion of the proposed experiments will
provide a detailed understanding of fat taste, and inform fundamental principles of sensory coding that may be
shared across phyla.

Public health relevance
Project Narrative Consumption of high fat food contributes to obesity and metabolism-related disorders that are increasing in prevalence and present an enormous health burden throughout the world. This proposal will investigate how dietary fats are detected and processed to promote food consumption. Functional investigation of the mechanisms regulating fat taste will further our understanding of feeding, obesity, and sensory processing.